The Goizueta Alzheimer's Disease Research Center

PROJECT SUMMARY/ABSTRACT: CLINICAL CORE
The primary goals of the Clinical Core are to support and enhance efforts of the Goizueta Alzheimer’s Disease
Research Center (GADRC) at Emory to advance cutting-edge research to identify mechanisms and
biomarkers of risk and protection, predictors of cognitive decline with emphasis on populations at greatest risk,
and factors that underlie heterogeneity in dementing illnesses. The Clinical Core plays a central role in the
GADRC by supporting the overall theme of explaining pathological and clinical heterogeneity of AD and related
disorders (ADRD) to enable precision in early identification, intervention, and prevention. To accomplish these
goals, the Clinical Core has well-defined processes to recruit, track, characterize, and retain a cohort of
longitudinal research participants and to effectively coordinate activities and share data with other Cores of the
GADRC and external partners. In the current funding period, the Clinical Core, in collaboration with the ORE
Core, accomplished its goals of implementing innovative programming and educational approaches to promote
successful engagement of the African American community, including enrollment of equal numbers of Black
and White participants. The Clinical Core also expanded enrollment of diverse underlying pathophysiologies
including vascular cognitive impairment, Lewy Body Disease, and Frontotemporal dementia. Coordinated
efforts with the Neuropathology, Biomarker, Imaging, and DMS Cores led to the harmonization of data and
biospecimen collection, and supported advances in local, national, and international research using mass
spectrometry-based proteomics. Aims for this renewal are to 1) Establish and maintain a diverse cohort of well-
characterized research participants to support priorities in current AD/ADRD research, with a continued
emphasis on African Americans and the planned expansion to participants of Asian ancestry; 2) Collect high-
quality data and biospecimens across a diverse population to support new discoveries in aging, resilience, and
heterogeneity of AD and ADRD; and 3) Support and facilitate the dissemination of best practices using new
diagnostic tests and emerging therapeutics, including spearheading the evaluation of digital cognitive
assessments, voice recording, and retinal imaging along with plasma biomarkers. Achieving these Specific
Aims will enable the Clinical Core to contribute to advances to unravel the heterogeneity of dementing
diseases, understand the impact of diverse influences, including ancestry and social determinants of health,
and translate these advances to deliver more precise diagnosis, treatment, and prevention of AD/ADRD.